Cornell ME/CFS Collaborative Research Center Administrative Core

PROJECT SUMMARY- ADMINISTRATIVE CORE
Cornell University will be the lead institution on the Cornell ME/CFS Collaborative Research
Center (CCRC), which constitutes a multi-institutional effort involving key personnel from four
Colleges within Cornell University in Ithaca, the Hospital for Special Surgery in New York City,
the Susan Levine Clinic, and Florida Atlantic University. The Administrative Core team will be
responsible for the organization and synergy of project personnel at the multiple sites and will
be responsible for effective oversight and management of all project operations, both scientific
and administrative. The Center will be managed by an experienced Center Administrator, who
will oversee the day-to-day operations including subcontracts with our partner institutions,
scientific coordination with the Research Core and with the data management and coordinating
center (DMCC) and other ME/CFS CRCs, as well as administrative, budgetary, scientific and
any other post-award aspects of the Center operations. In addition, the project team will be
guided by several committees, an internal Executive Committee and a
Patient/Advocate/Caregiver Advisory Committee (PAC). The overall goal of the Administrative
Core of this Center is to ensure effective administrative and organizational capabilities, both
within our Center, and within the broader ME/CFS CRC network, and to operate a successful
outreach program to bring the importance and current knowledge of ME/CFS to a wider
audience. The Administrative Core will work to create synergy among the research projects, the
Research Core and the Outreach components of the Center to create a seamless, well-
functioning unit.